PROPERTIES OF IMMUNOGLOBULIN SECRETING CELLS

Continous cell cultures obtained by in vitro transformation of bone marrow cells with retroviruses containing ras or raf and myc were found to exhibit characteristics of both B cell lineage any myeloid cells. Analyses of cloned derivatives of these cultures showed that lines with phenotypes of mature B cells or mature macrophages could be isolated but that these lines were clonally related. These results indicate that some B cells and myeloid cells can develop from a common progenitor. The role of altered myc expression in plasmacytoma development was studied by inoculating pristane-primed BALB/c mice with a retrovirus expressing avian v-myc. Over 25% of infected mice developed plasmacytomas that lacked chromosomal translocations affecting the c-myc locus. Instead, the tumors contained and expressed high levels of v-myc. These results provide the most direct evidence to date for a central role for altered myc expression in plasmacytomagenesis. Mice transgenic for the membrane form of human IgM were studied for expression of murine and human IgM on B cells. By flow cytometry, B cells but not T cells or macrophages were shown to express the transgene. In addition, it was found that B cells expressed either human IgM or mouse IgM indicating that the membrane form of IgM can signal allelic exclusion.